Preanalytical Validation of Circulating Tumor DNA from Surgical Drain Fluid as a marker of Postoperative Minimal Residual Disease in Head and Neck Squamous Cell Carcinoma

PROJECT SUMMARY
Head and neck squamous cell carcinoma (HNSCC) remains a significant global health burden with
one million new cases annually. HPV-negative (HPV-) HNSCC, which is the most common and
deadliest form, is particularly problematic given its high rate of recurrence after curative-intent surgical
resection. Unfortunately, current criteria for adjuvant therapy are imprecise and subject to variability,
and there are no reliable biomarkers to detect minimal residual disease (MRD) post-surgery.
Traditional plasma-based liquid biopsies are limited in sensitivity for locoregional recurrence and low
tumor volume settings. To address these issues, our team has developed a novel approach using
surgical drain fluid (SDF) collected postoperatively as a proximal bioanalyte to measure MRD in
HNSCC patients. Our published preliminary data indicate that circulating tumor DNA (ctDNA) in SDF
predicts locoregional relapse and progression-free survival with higher sensitivity and specificity than
postoperative plasma ctDNA. Tumor-derived exosomes (TEX) in SDF also show potential as
prognostic biomarkers. This proposal aims to systematically investigate the pre-analytical variables
related to this new liquid biopsy analyte, with the goal of establishing standard operating procedures
(SOPs) for SDF-based ctDNA and TEX assays to accurately measure MRD after HNSCC surgery.
We propose three specific aims: (1) optimize postoperative collection and processing methods for
SDF to enhance ctDNA recovery and stability by evaluating preanalytical variables such as collection
timing, preservation solutions, centrifugation spins, temperature, and processing time; (2) optimize
conditions for isolating TEX and TEX-associated DNA from SDF in HPV-positive and HPV-negative
HNSCC patients using immune capture techniques and TEX luminal DNA quantification; and (3)
validate SDF ctDNA for prognostication of relapse in a prospective HPV-negative HNSCC cohort,
correlating SDF ctDNA detection after surgery with recurrence outcomes and comparing SDF ctDNA
with SDF TEX. This research has the potential to revolutionize postoperative management and
adjuvant therapy personalization for head and neck cancer patients based on optimized SDF SOPs,
thus improving survival outcomes and reducing treatment-related morbidity.

Public health relevance
PROJECT NARRATIVE Head and neck squamous cell carcinoma (HNSCC), particularly the HPV-negative subtype, poses a significant health challenge due to a lack of reliable biomarkers for detecting minimal residual disease (MRD) after curative-intent surgery. This project aims to develop and validate a novel liquid biopsy approach using surgical drain fluid (SDF) collected postoperatively to enhance the detection of MRD through circulating tumor DNA (ctDNA) and tumor-derived exosomes (TEX). By establishing optimized standard operating procedures for SDF-based assays, this research seeks to improve the precision of adjuvant therapy decisions, ultimately enhancing survival outcomes and reducing treatment-related morbidity in HNSCC patients.